Supplemental Request for Mechanical Modulation of Cell Migrations by DNA Nanoassemblies

Summary. This proposal seeks to test whether mechanical affinity of the complex between RGD, a tripeptide
domain found in proteins of extracellular medium, and integrin, a cell membrane receptor protein, is correlated
with cell migrations. By attaching the RGD ligand to a magnetic bead via a DNA handle, integrins on cell
surface can be evaluated for their binding affinity to the RGD by mechanically pulling away the binding
complex using a pair of magnets in magnetic-tweezers instrument. During the pulling, a camera in the
magnetic-tweezers setup is employed to record the distance between the magnetic bead and the magnet pair,
which is converted to the binding force at the time of bead detachment. The same camera is also used to
simultaneously monitor cell morphology changes that are related to cell migrations. Such a setup allows to
correlate the mechanical affinity of the RGD-integrin complex to the cell migration. This new technique has also
been successful in measuring the extraction force of lipid molecules such as cholesterol away from the cell
membrane.
Cholesterol is a critical component to increase the rigidity of the lipid rafts in the cell membrane. Cell migration
is shown to be inhibited when lipid rafts are dissolved. Cell membrane receptors such as EGFR, HER2, and
CD36 are found within lipid rafts. They may be impacted by compromised lipid rafts after cholesterol depletion.
All these three receptors play a role in cell migration through cell signaling pathways such as the Src-Fak axis.
We propose that these receptors may induce changes in cell migration when the structure and property of lipid
rafts are altered by factors such as cholesterol supplement/depletion or overexpression/knock-down of
EGFR/HER2/CD36 receptors. Integrin-RGD mechanical affinity will be used as a marker to follow changes in
cell migration as integrin binds to the extracellular matrix via peptide domains such as RGD. When lipid rafts
change their properties, integrin-RGD mechanical affinity may alter, which leads to variation in cell migration.
Previously, mechanical affinity has been shown to correlate with binding affinity; however, it is unknown if
mechanical affinity coordinates with intracellular signaling. By depleting cholesterol, migration will be inhibited.
We expect that supplementation of cholesterol after depletion may restore cell migration. To investigate this
restoration, we will evaluate changes in cell migration at either extracellular or intracellular level. At the
extracellular level, we will again use the mechanical affinity of integrin-RGD as a marker for cell migration. At
the intracellular level, western blot analysis will be used to follow changes in cell signaling by monitoring
expression levels of phosphorylated proteins associated with cell migration. We aim to test if extracellular
mechanical binding force corresponds with intercellular signaling as changes in migration occur. In summary,
we will evaluate cell migration using integrin-RGD mechanical affinity when changes in lipid raft composition
occur (Aim 1) and test if changes in mechanical affinity correspond with cell signaling intensity (Aim 2).

Public health relevance
Project Narrative This project will test that the mechanical stability between RGD, a tripeptide, and integrin is correlated with cell migration. The project will also evaluate the effect of cell membrane receptors, such as Epidermal Growth Factor Receptor (EGFR), on cell migration. The knowledge obtained will help to fight various diseases associated with abnormal cell migrations.